Understanding Mediating and Moderating Factors that Determine Transfer of Working Memory Training

PROJECT SUMMARY
This proposal aims to improve the rigor and reproducibility of research on plasticity in human working memory
(WM), and related executive functions (EFs) in adolescent youth. We address a critical gap between research
and practice that is characterized by a growing commercial space marketing cognitive training approaches (with
WM being one of the most common targets), which are particularly catering to typically developing children and
those diagnosed with ADHD to improve mental health and scholastic performance. However, despite expansive
literature, there exists limited basic research on WM and EF training in adolescents, and both methods and
findings are mixed across studies. Here, we address these significant gaps that pose obstacles to understanding
interventions’ reliability and validity by collecting a large-scale open dataset that compares different training
approaches on a common set of outcome measures. This is addressed through 4 aims, all based upon a large-
scale study involving 720 adolescents, stratified across age, sex and ADHD status randomized across
interventions: Aim 1 – What ingredients of cognitive training mediate training outcomes? We compare training
conditions that represent some of the most common ingredients used across cognitive training studies
(gamification, multiple domain training, and coaching) in comparison to basic non-gamified n-back training, using
a common set of outcomes measures. Aim 2 – How do training ingredients differentially impact youth with
ADHD? With ADHD being one of the most common targets of cognitive training, we examine whether and how
youth with ADHD are differentially impacted by the training conditions. Aim 3 – What individual characteristics
moderate training outcomes? We examine how cognitive training outcomes may differ across individuals, and
whether this variability may explain differential effects across studies. Aim 4 - Promote open science through
sharing of software tools and data. We will develop and share a cross-platform training and assessment app and
a research portal that will promote data sharing, replication, and access to other groups using common individual
difference variables and outcome measures. As a renewal, targeting adolescents with and without ADHD is a
natural next step in this research program that started in typically functioning adults. This research is significant
and timely as it addresses the limited basic research of cognitive training in adolescents with and without ADHD,
whom are understudied, but at the same time, are common targets of commercial products in this space. This
will lead to a more robust and representative understanding of factors that moderate and mediate cognitive
training that will be impactful whether or not one hypothesizes near or far transfer from cognitive training. Further,
findings could inform future research to understand broader age groups (younger children and older adults) as
well as to address lifespan and developmental factors more broadly, mental health, disease, and brain damage,
that interact with cognitive training to give rise to individualized outcomes.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health in that it aims to achieve greater understanding of, and creation of more effective, cognitive interventions for typically developing adolescents as well as youth diagnosed with Attention-Deficit Hyperactivity Disorder (ADHD). This research is aligned with the NIMH mission of transforming the understanding and treatment of mental illnesses in that it seeks to develop and test an accessible and low-cost intervention to improve cognitive function and mental health in diverse populations using an innovative telemedicine approach. The proposed research cuts across the bounds of numerous NIH agencies, with our framework contributing to the missions of the NIMH, NICHD, NIA, NCI, NEI, NIAAA, NINCD, NIDA, and NINDS, in that all of these agencies work with populations who can gain direct benefits from successful approaches to remediate cognitive deficits and improve mental health, and the NIH’s greater mission to seek knowledge that will result in enhanced health and a reduced burden of disabilities, and ultimately, transform mental health care.